Deep Learning-based retinal optical coherence tomography markers for optic neuropathies

PROJECT SUMMARY/ABSTRACT
Optic neuropathies, a wide-ranging group of eye diseases, primarily target the optic nerve and frequently result
in irreversible vision loss. Globally affecting millions, these conditions stem from a variety of causes such as
glaucoma, ischemic, inflammatory, compressive, toxic, and hereditary factors, each with distinct
pathophysiological traits. Characterized by the degeneration of retinal ganglion cells, these diseases lead to
changes in the optic nerve head and visual field defects. The diverse onset and myriad underlying causes of
these neuropathies complicate early diagnosis, underscoring the necessity for advanced diagnostic tools.
This project proposes leveraging deep learning-based morphometric analysis in optical coherence tomography
(OCT) to develop innovative biomarkers for optic neuropathies. OCT, a non-invasive imaging technique, has
revolutionized the diagnosis and management of these conditions, providing detailed retinal and optic nerve
head imagery. However, its efficacy is limited by device-dependent variability, signal quality dependency, and
insufficient sensitivity of current thickness markers in chronic disease monitoring.
This project proposes to overcome these limitations by employing advanced computational techniques such as
deep learning, neural fields, and geometric modeling. These methods excel in extracting complex patterns from
medical images and enhancing the accuracy of morphometric analyses. Geometric deep learning adapts to the
neuroretina's geometric structures, offering novel insights into the optic nerve head and macula. Neural field
image registration enhances OCT image co-registration accuracy, crucial for longitudinal disease monitoring.
The project aims to revolutionize the diagnosis and management of optic neuropathies through three
interconnected objectives. The first aim is to employ deep generative models for mapping structure-function
relationships in optic neuropathies, focusing on predicting visual field outcomes and tracking disease progression
using advanced deep learning techniques. The second aim is to pioneer the next generation of retinal
morphometric OCT biomarkers using deep learning, enhancing the precision in identifying retinal changes and
improving the longitudinal analysis of optic nerve head and macular structures. Finally, the third aim is dedicated
to leveraging deep learning models for the classification of various types of optic neuropathies directly from
retinal OCT scans, aiming to significantly increase the accuracy and efficiency in distinguishing these conditions.
This research proposes a multidimensional strategy to significantly improve the diagnostic and management
capabilities in the field of neuro-ophthalmology through innovative applications of deep learning to OCT imaging.
By integrating advanced imaging techniques with deep learning models, it aims to unveil novel biomarkers and
predictive models, offering insights into the progression and treatment of these complex eye diseases. The
success of this project could lead to earlier detection, personalized treatment strategies, and ultimately, better
outcomes for patients with optic neuropathies.

Public health relevance
NARRATIVE Optic neuropathies, a group of disorders leading to irreversible vision loss due to retinal ganglion cell degeneration and optic nerve damage, present a significant challenge in ophthalmology, primarily due to delayed diagnosis and diverse etiologies. This research aims to investigate the detection and management of these diseases by harnessing deep learning and computational techniques to analyze optical coherence tomography (OCT) data. By developing precise biomarkers and utilizing advanced methods like deep generative models, geometric modeling, and neural fields, the project seeks to improve early diagnosis, accurately predict disease progression, and facilitate personalized treatment strategies, addressing the critical need for timely intervention in optic neuropathies.